Mayo Advancing Research Equity in ADRD Study in Jacksonville(MAREAS-Jax)

PROJECT SUMMARY/ABSTRACT
Hispanics/Latinos (HL) and African Americans (AA) represent a rapidly growing proportion of the United States
population (18.7% HL, 12.4% AA - US 2020 Census) who remain critically underrepresented in research of
Alzheimer disease (AD) and AD-related dementia (ADRD), despite a 1.5-2-fold higher prevalence of dementia
(vs non-Hispanic-white Americans). Underrepresentation in AD/ADRD research exacerbates health disparities
and challenges the development and implementation of efficacious and safe risk-reduction strategies for
AD/ADRD in HL/AA. Genetics do not fully explain disparate AD/ADRD risk, highlighting a fundamental
knowledge gap concerning how genomic factors interact with comorbidities and lifespan exposures to
Structural/Social Determinants of Health (SDoH; the “exposome”) to inform AD/ADRD risk. There is a critical
need to identify clinical, SDoH, and biological factors that contribute to disparate risk in HL/AA; establish the
relationship between exposures underlying AD/ADRD outcomes; use this information to mitigate disparities in
AD/ADRD burden through education and risk factor modification; and broadly disseminate this information to
inform the development of effective biomarkers and therapies. The Mayo Advancing Research Equity in ADRD
Study in Jacksonville (MAREAS-JAX; Spanish for tides) will address this need. Aim 1 will advance recruitment
of HL/AA cohorts (UH2) by developing/deploying outreach, recruitment, and engagement best practices for
HL/AA in Jacksonville, Florida, through a bilingual (English-Spanish) research team, supported by community
ambassador teams (CAT) and an external advisory committee (EAC) including experts in SDoH and AD/ADRD
research. Aim 2 will identify relevant measures of AD/ADRD burden (UH2►UH3). SDoH, cognitive, clinical, and
blood-based biomarker measures associated with cerebrovascular, amyloid, and tau burden, will be collected
through comprehensive/culturally appropriate annual assessments and integrated with multi-omics data,
structural (MR) and molecular (amyloid and tau) PET neuroimaging obtained at study entry, and every 2 years
thereafter to identify modifiable dementia risk factors, blood-based biomarkers, and molecular signatures of
AD/ADRD burden. Data collection will be standardized with input from EAC members to optimize scalability and
promote sample/data sharing. Aim 3 will provide meaningful individualized feedback (UH3) to participants
through a Brain Health Report detailing actionable risk factors and recommendations to mitigate intraindividual
AD/ADRD burden. Aim 4 will use multi-omics measures to identify molecular targets and signatures that interact
with the exposome and associate with AD/ADRD burden in HL/AA (UH3) using a systems biology approach with
validated analytic pipelines and prioritizing broad data sharing following NIH’s findability, accessibility,
interoperability, and reusability guidelines. In this way, MAREAS-Jax will chart the currents that drive
disproportionate participation in AD/ADRD research and disparate AD/ADRD burden and will inform the design
and implementation of strategies to shift these tides in Northeast Florida and beyond.

Public health relevance
PROJECT NARRATIVE The Mayo Advancing Research Equity in ADRD Study in Jacksonville (MAREAS-Jax; Spanish for tides) will support the development of infrastructure to recruit and engage Hispanic/Latino Americans and African Americans in a longitudinal research program designed to characterize the contributions of genetic, medical comorbidities, and lifespan influences of Structural/Social Determinants of Health (the “exposome”) to disparate burden of Alzheimer disease and related dementias. Real-time communication of brain health risk factors will empower participants to mitigate risks and improve overall brain health. Neuroimaging and blood-based biomarkers of amyloid, tau, neurodegeneration, and vascular burden together with multi-omics measures will inform the relationship between the exposome and Alzheimer disease and related dementia burden within and across individuals.